Clinical Protocol and Data Management

PROJECT SUMMARY
CLINICAL PROTOCOL & DATA MANAGEMENT
Clinical Protocol & Data Management (CPDM) provides comprehensive support for Moffitt Cancer Center
(Moffitt) investigators that facilitate development and testing of new treatments, prevention strategies, supportive
care, diagnostics, and biomarkers to translate them to the point of patient care. CPDM provides support through
a talented centralized team that oversees the design, development, and conduct of interventional and
observational trials; trial safety and compliance; data quality; personnel education; and appropriate accrual of
women, minorities, and persons across the lifespan. CPDM activities are organized into four Specific Aims:
Aim 1: To support investigators in development, implementation, and conduct of innovative cancer clinical
studies, with a particular emphasis on investigator-initiated trials (IITs)
Aim 2: To ensure safety and compliance through timely monitoring, audits, and committee oversight
Aim 3: To provide comprehensive clinical research training and education, along with ongoing quality assurance,
to meet the highest standards of research data and study patient care
Aim 4: To facilitate appropriate inclusion of women, minorities, persons across the lifespan, and other
underserved populations in clinical research studies
Progress has included accruing 16,321 patients to interventional trials and 5,716 to treatment trials, representing
a 38% increase in total trial interventional accruals since the previous reporting period. As a result of a 36-point
clinical research action development plan, treatment accruals increased by 25% in FY2020 as compared to
FY2015. Safety and compliance for these trials is overseen by the Protocol Monitoring Committees and is
coordinated by the CPDM team under a revised NCI-approved Data & Safety Monitoring Plan.
Moffitt has diligently worked to increase accruals of women, minorities, and persons across the lifespan through
its Minority Clinical Research Committee by: 1) establishing a committee called Reaching & Engaging Special
Populations to Expand Clinical Trials (RESPECT); 2) increasing minority community outreach and clinical
research education events; and 3) establishing Moffitt-led trials at affiliate sites. These efforts resulted in
Hispanic/LatinX accrual of 39.3% interventional and 7.8% treatment and African American/Black accrual of 6.3%
interventional and 5.9% treatment, with plans to further increase inclusion. During the reporting period, 48% of
patients accrued were women, which is similar to patients seen at Moffitt. Moffitt primarily serves adult patients.
Age at time of accrual ranged from 18 – 94 (with 52% among being populations >65), ensuring that individuals
across the lifespan participate in clinical trials at Moffitt. Overall, CPDM supports Members engaging in high
impact clinical research by providing key compliance, coordination, and clinical outreach services throughout the
trial lifecycle, from protocol development to closeout, ensuring the conduct of rigorous and innovative
interventional and observational trials that benefit patients in our catchment area and beyond.